The Sex-specific Roles and Neural Processing Correlates of Future Outcome Estimation in the Drug Addiction Process

Project Summary
Our daily decisions are rooted in the ability to forecast possible decision consequences into our future. This
ability to mentally simulate a future event, referred to as prospection, enables self-control by biasing decisions
by their projected future gains or costs. The working hypothesis of the revised proposal is that addiction’s
onset and chronically relapsing nature reflect developmental immaturity and disorders, respectively, of the
human faculty of future-oriented thinking. Project hypotheses would be tested via core project tools of
temporal delay discounting to weigh future-oriented thinking on the valuation of behavioral reinforcers, task-
related fMRI as a means of mapping neural processing mechanisms underlying future-oriented thinking,
assessments evaluating individual differences in future-oriented perspectives, and the use of “episodic tags”
as framing stimuli to engage episodic future thinking (EFT). These tools would define individual, sex, and
developmental group differences across three specific aims to test the project overall and component
hypotheses. Aim 1 would explore the sex-dependent relationship between behavioral and neural correlates
of future-oriented thinking [assessed using delay discounting (DD) tasks] and conditioned drug cue-related
cognitive bias [assessed by the cocaine attentional bias effect (cocAb)] among men and women with cocaine
addiction. Ecological relevance is enhanced by the characterization of both DD gains and losses, with losses
being more typical of addiction-related futures. Adolescence is associated with developmentally immature
behavioral and neural processing representations of future-oriented thinking, representing a period associated
with greatest risk for the onset and escalation of drug misuse. Aim 2 would extend project goals to explore
sex-dependent developmental processes related future orientation during early to mid-adolescence with the
initiation of the addiction (and well-recognized addiction risk factors) – thus testing if addiction-related EFT
deficits reflect acquired versus pre-existing traits. Samples of adolescent girls and boys would be compared
across stratified levels of addiction risk. An interesting aspect of EFT relates to its ability, when explicitly
engaged by episodic cues (“tags”) promoting future orientation, to reduce both temporal discounting rates
and real-world health risk behaviors. Aim 3 would define the sex-dependent impact and mechanisms of the
induction of EFT (EFTi) on gain and loss DD among at-risk adolescents and cocaine-addicted adults. This
translational aim would initiate the evidence basis for the potential use of EFT training in prevention strategies
for adolescents at-risk for drug use disorders or as an adjunctive approach to relapse prevention in treatment-
seeking individuals with drug use disorders. Across project Aims, 6-month follow-up assessments would
assess the relationship of future orientation to future drug misuse. The proposed project would characterize an
underexplored facet of decisional impulsivity – its regulation by prospection – in the drug addiction process.

Public health relevance
Project Narrative The short term goals of the proposed project are to 1) explore the role of addiction-related deficits in future orientation as diminished self-control processes that normally bias motivation away from impulsive choices for immediate reinforcers, 2) model the underlying neural information processing correlates of these future-oriented behaviors, and 3) define the roles and mechanisms by which developmental maturation of future-oriented thinking across early-mid adolescence contributes to the development of drug use disorders. The revised project would also define sex differences in the roles and mechanisms of future orientation in the development and maintenance stages of the addiction process. The long-term goal of the project is to provide a novel science-based rationale for the application of manipulations of EFT as interventions to prevent and treat drug addiction.